CORE--PATHOLOGY

(Adapted from the applicant's abstract) To provide histopathology and cytology support for Projects 1, 2, and 3. Specifically, the Pathology Core will involve histopathologic and cytologic evaluation of tissues and culture cells using conventional morphology coupled with sophisticated immnohistochemical evaluation of tissues and cell suspensions.